Structural and biochemical characterization of VCPIP1 and VCP complex

Project Abstract/Summary
The ubiquitin proteasome system (UPS) is an integral part of determining protein fate. Proteins are
marked with ubiquitin for degradation by the proteasome through the activity of an enzymatic cascade
(ubiquitination). Deubiquitinating enzymes (DUBs) remove ubiquitin from proteins rescuing them from
degradation1. Together ubiquitination and deubiquitination control protein stability and homeostasis and are
essential for metazoan development and aberrant regulation implicated in disease such as cancer. Inhibitors of
the UPS, such as Bortezomib, are effective cancer therapeutics. With knowledge of the structure and function of
DUBs, inhibitors for DUBs can be developed as precision therapies. An example of an application of DUB
inhibitors in cancer biology is stabilization of oncoproteins, such as c-Myc1, that are stabilized by a DUB. Valosin
containing protein p97/p47 complex interacting protein 1 (VCPIP1), a member of the OTU family of DUBs2, is a
cysteine protease that, like many of the DUBs, has been identified as a therapeutic vulnerability in human
cancers3. Its known close interactor, valosin containing protein (VCP)4, is a key player in the UPS system as it
unfolds a variety of poly-ubiquitinated substrates prior to their degradation by the proteosome, and is itself a
promising therapeutic target5. The protein unfolding by VCP is remarkable and unique as it is able to unfold
ubiquitin, a notoriously stable protein that initiates the unfolding of poly-ubiquitinated substrates6 prior to DUB
activity at the bottom of the channel. There is no knowledge as to how and why VCPIP1 binds to VCP.
Preliminary data from a co-purification from mammalian cells and immuno-precipitation mass
spectrometry (IP-MS) confirm that VCPIP1 interacts with VCP. Using cryo-electron microscopy (cryo-EM), initial
data collection using a Talos Arctica and data processing with cryoSPARC7 resulted in high quality 2D classes
with secondary structure features and, ultimately, a 3.3 Å 3D reconstruction. Titan Krios data collection of
chemically crosslinked sample resulted in a 3.0 Å reconstruction of the complex without substrate. This provided
initial insights into the interaction site of VCPIP1 and VCP and the general stoichiometry of the complex.
Using structural and biochemical methods, this proposal aims to elucidate the structure of VCPIP1 and
its mechanism of interaction with VCP, why VCPIP1 forms a complex with VCP and how it acts on clients. This
effort together with initial hit compounds will enable the development of inhibitors for VCPIP1. Specifically,
Specific Aim 1 aims to solve a high-resolution structure of VCPIP1 bound to VCP using cryo-EM and to
biochemically characterize the interaction between VCPIP1 and VCP by structure-function studies. Specific Aim
2 aims to determine a high-resolution structure of the VCPIP1/VCP complex bound to a substrate and adaptors,
fluorescence/enzymology assays will be used to demonstrate deubiquitylation by VCPIP1 after substrate
unfolding by VCP. Specific Aim 3 aims to use structure-based drug design (SBDD), both computationally and
experimentally, to discover and improve VCPIP1 inhibitors.

Public health relevance
Project Narrative VCPIP1, an anti-tumor target and a deubiquitinase in the DUB OTU family, is abundant in many cancers and can be characterized using structural biology methods. Using structure-based drug discovery (SBDD) methods, I propose to utilize the unknown structure of VCPIP1 in complex with VCP to help optimize inhibitor activity within the drug discovery process. I expect this to make a profound impact in therapeutics and human health.